3D Printed Microfluidic Artificial Lung for Veteran Rehabilitation

The long-term goal of this technology development project is to improve rehabilitation of Veterans suffering
from lung disease through the development of the first truly portable, biocompatible, artificial lung capable of
short and long term respiratory support. Current artificial lungs have recently been used to rehabilitate lung
disease patients; however, significant advances in gas exchange, biocompatibility, and portability are required
to fully realize their potential. Microfluidic artificial lungs promise to enable a new class of truly portable artificial
lungs through feature sizes and blood channel designs that closely mimic those found in their natural
counterpart. However, current microfabrication techniques limit the microfluidic networks in these devices to
two dimensions, thereby severely limiting potential device topologies and resulting in inefficient blood
distribution networks. Further, current construction techniques may not be suitable for the large area
production required for human applications. In this study, we will for the first time harness high resolution 3D
polymer printing technology to create large area microfluidic lungs with truly three dimensional blood flow
networks and topologies. Constructed 3D printed microfluidic artificial lungs will exhibit gas exchange suitable
for some human applications, while using a fraction of the blood contacting surface area, blood volume, and
total volume of current commercial devices. The objectives of the current technology-development Merit
proposal are thus to: 1) optimize resin [resolution, permeability, toxicity, and blood compatibility] for microfluidic
artificial lungs; 2) Construct an adult-scale 3D printed microfluidic lung and validate in vitro; and, 3) Acute and
chronic in vivo testing of an adult-scale µAL. At the conclusion of this study, we will be ready to for extended
testing of our 3D printed microfluidic artificial lungs in a large animal model and for scaling up to larger rated
blood flows. The listed objectives are thus critical to advancing this promising technology towards initial acute
systems for Veteran pulmonary rehabilitation.

Public health relevance
Chronic obstructive pulmonary disease (COPD) affects approximately 16% of the veteran population. COPD is the fourth most prevalent disease in the VA population and one of the most costly to the VA health care system. Over 500,000 service-connected respiratory disabilities have been diagnosed in veterans and 6.5% of all Gulf War service-connected disabilities are respiratory system related. Operation Enduring Freedom and Operation Iraqi Freedom Veterans have been exposed to chemicals known to cause acute and chronic respiratory conditions including CARC paint and chromium dust. Other veterans have experienced acute lung failure from blast injury, smoke inhalation, or COVID-19. Over 2.3 million veterans reported having some form of “lung trouble” in the 2001 National Survey of Veterans. This project has the potential to revolutionize the rehabilitation of Veterans suffering from lung disease through the development of a truly portable, biocompatible, artificial lung prothesis.